Traumatic and Treatable Vascular Pathology in the Outcome of TBI

Objective: The overarching objective of this career development proposal is to develop Dr. Swanson’s
translational approach for investigating the relationship between mild traumatic brain injury (mTBI) exposure(s),
modifiable cardiovascular risk factors, and non-invasive measures of chronic cerebral microvascular pathology,
including advanced neuroimaging modalities.
Research Design and Methodology: Through resource sharing, previously collected and archived clinical
data, neuroimaging data, and blood samples from the joint DoD/VA Long-Term Impact of Military-Relevant
Brain Injury Consortium – Chronic Effects of Neurotrauma Consortium (LIMBIC-CENC) Prospective
Longitudinal Study Cohort will be utilized to perform a retrospective cohort study.
Aim-I will investigate potential associations between mTBI exposure(s) and advanced neuroimaging measures
of chronic cerebral microvascular pathology. Primary analysis will explore associations between the number of
mTBI exposures (none, 1-2, or 3+) and two independent advanced neuroimaging measures of cerebral
microvascular pathology (white matter hyperintensity quantification with Brain Intensity Abnormality
Classification Algorithm [BIANCA] analysis, and diffusion-MRI Free Water Volume Fraction [FW-VF] analysis)
at a single point in time (initial neuroimaging acquisition upon entry into the LIMBIC-CENC study), adjusting for
both age and sex. Secondary analysis will further categorize the mTBI exposure history into 7 severity
subgroups (accounting for the presence or absence of associated post-traumatic amnesia and loss of
consciousness), and then explore associations between resulting mTBI exposure severity and BIANCA / FW-
VF advanced neuroimaging analysis, adjusting for age and sex.
Aim-II will investigate potential associations between modifiable cardiovascular risk factors and advanced
neuroimaging measures of chronic cerebral microvascular pathology. Using a combination of ideal
cardiovascular health (I-CVH) behaviors (physical activity, sleep duration, smoking and alcohol use) and
factors (body mass index, blood pressure, total cholesterol, and diabetes mellitus status), we will calculate
patient-specific I-CVH Index scores and explore associations with BIANCA / FW-VF neuroimaging measures of
cerebral microvascular pathology, adjusting for age, sex and mTBI exposure(s) as independent risk factors. In
addition, we will evaluate longitudinal changes in cerebral microvascular pathology at 1, 3 & 5-year follow-up.
Candidate, Career Goals, Research Career Development: Dr. Randel Swanson is a prior enlisted U.S.
Marine who is board-certified in Physical Medicine & Rehabilitation, with subspecialty board certification in
Brain Injury Medicine. He is an Assistant Professor of Physical Medicine & Rehabilitation at the University of
Pennsylvania, and an Attending Physician at the Corporal Michael J. Crescenz VA Medical Center, where he
serves as a Polytrauma/TBI System of Care team physician. Dr. Swanson’s immediate career goals are to
acquire the necessary technical knowledge and leadership skills to coordinate a multidisciplinary translational
research team focused on investigating cerebral microvascular pathology in TBI and cardiovascular disease,
with the long-term career goal of sustaining a translational research career within the VA Healthcare System.
To achieve these goals, Dr. Swanson has put together an expert mentorship team, and will receive advanced
training through Penn’s Institute for Translational Medicine and Therapeutics. At the end of the CDA2 period, it
is expected that Dr. Swanson will have established a robust VA-based translational TBI laboratory.

Public health relevance
Long-term neurological consequences of traumatic brain injury (TBI) may be the most critical issue facing Veterans over the next 50 years, given that TBI has become a signature injury of modern warfare. Large cohort studies in both civilian and Veteran populations have clearly demonstrated an association between TBI and an increased incidence of dementia diagnosis with advancing age. Thus, there is a critical need to identify pathophysiological mechanism(s) underlying progressive age-related neurodegeneration which are amenable to modifiable lifestyle and/or therapeutic interventions decades before the clinical presentation of cognitive impairment or dementia. This proposal aims to investigate the impact of modifiable cardiovascular risk factors on chronic TBI-related sequelae, a goal in-line with the VA’s strategic mission to implement “Whole Health for Life,” “the radical redesign of healthcare” within the VA.